Cellular Adaptations to Nutrient-Limited Metabolic Microenvironments

Project summary
My laboratory discovers metabolic adaptations required for cells to function, proliferate, and survive in
low-nutrient metabolic environments, identifies small molecule inhibitors that target these metabolic
vulnerabilities, and develops techniques to discover new metabolites and metabolic pathways. Cells require
nutrients to make biomolecules required for growth and proliferation, and restricted availability of these nutrients
prevents cell growth. Nutrient limits are imposed by the extracellular environment, such as the brain interstitial
fluid, which maintains low levels of amino acids such as serine and glycine. These amino acids serve as
neurotransmitters, and are needed to make proteins, nucleotides, and antioxidants. Cells also make some
metabolites, such as coenzymes, in limiting quantities. Coenzymes are organic cofactors required for all
metabolic pathways, and in unicellular organisms are made in a “just-in-time” manner to match cell growth. In
addition to carbon and nitrogen-based nutrients, most of the human body, including the brain and bone marrow,
maintains physiologic oxygen tensions below ambient oxygen availability. Oxygen is used for cellular respiration,
but also is the substrate for a variety of enzymes, such as the dioxygenases, that synthesize metabolites and
maintain epigenetic homeostasis. Both acute and chronic nutrient depletion and hypoxia contribute to the
pathogenesis of many diseases including autoimmune disease, cardiac disease, and cancer. Cells entering,
growing, or proliferating in the brain or other low-nutrient environments must find other sources of serine, glycine,
and coenzymes or synthesize their own, and prioritize the efficient use of nutrients and oxygen.
Over the next five years, we will identify the metabolic adaptations needed for cells to enter the brain,
determine if cells acquire these adaptations before they enter the brain or adapt following entry into the brain,
and target these adaptations with small molecule inhibitors. These studies will reveal metabolic targets whose
inhibition could prevent diseases caused by cells inappropriately entering the brain, and offer proof of concept
that targeting these adaptations would be of therapeutic value in diseases ranging from autoimmune disease to
brain metastases. We also will define the enzymes, intermediates, and regulatory mechanisms of the mammalian
Coenzyme Q10 headgroup synthesis pathway, which we recently discovered, and determine how cells produce
the precise quantities of coenzymes needed for cell growth. Finally, we have developed novel techniques for
tracing isotopically labeled gases into metabolites. We will use these techniques to discover metabolic pathways
critical for the survival of cells in low-oxygen environments. These pathways have evaded discovery due to
metabolic pathway redundancy or metabolite sharing. These projects will address longstanding unanswered
questions in metabolic adaptation, reveal coenzyme-dependent mechanisms of cell growth control, and
systematically identify new oxygen-dependent vulnerabilites in intermediary metabolism.

Public health relevance
Project Narrative The human body contains metabolic microenvironments, such as the bone marrow and brain, that are low in nutrients and oxygen. Eukaryotic cells must adapt to limited nutrients to proliferate and survive in these environments. We will determine the metabolic pathways prioritized by cells in nutrient-poor and hypoxic metabolic milieus using novel techniques of our own design.